Long-range function of the ERV-9 LTR in regulating globin gene switching

Project Summary/Abstract The solitary LTRs of the ERV-9 human endogenous retrovirus are associated with 3000-4000 human gene loci including the β-globin gene locus, where the ERV-9 LTR is located near the 5' end of the locus control region (LCR) 40-70 kb upstream of the ¿- and ¿-globin promoters. The ERV-9 LTR enhancer contains recurrent CCAAT and GATA motifs. The CCAAT motifs bind the ubiquitous transcription factor NF-Y, which recruits erythroid factor GATA -2 to the neighboring cognate site in the assembly of an active LTR enhancer complex NF-Y/GATA-2. In transgenic (Tg) mice carrying a 100 kb BAC spanning the entire human β globin gene locus, deletion of the ERV-9 LTR suppressed transcription of the ¿-globin gene and re-activated the ¿-globin gene during erythroid development in the erythroid cells of the Tg mice. We subsequently found that in the ΔLTR Tg mice, LTR deletion lowered the levels of NF-Y, GATA-2 and CBP on the ¿-globin promoter but increased the levels of these factors on the ¿-globin promoter in adult erythroid cells, in correlation with the reciprocal switching of globin gene transcription. The objective of this application is to test the hypothesis that the competition for interaction with the ERV-9 LTR and binding to LTR-associated NF-Y, GATA -2 and CBP/p300 between the ¿- and ¿-globin promoters regulates transcription and switching of the globin genes in the BAC Tg mice and in primary human erythroid progenitor cells undergoing in vitro erythropoiesis. In aim 1, we will use electrophoretic mobility shift assay (EMSA) and chromotin immunoprecipitation (ChIP) to determine if the levels of NF-Y, GATA-2 and CBP/p300 associated with the γ- and the β-globin promoters change in correlation with the transcriptional activities of the globin genes during erythroid development in BAC Tg mice and human erythroid progenitor cells and if the levels of these factors associated with the g- and b-globin promoter complexes are altered at the respective developmental stages in ΔLTR Tg mice. We will use GST-pulldown, co-immunoprecipitation (co-IP) and transfection assays to identify the interacting sub-domains in NF-Y, GATA-2 and CBP/p300 involved in the assembly of the NF-Y/GATA-2/CBP/p300 transcriptional complex in vitro and in erythroid cells in vivo. In Aim 2, we will use ChIP and chromosome conformation capture (3C) to determine if the ERV-9 LTR physically interacts with the LCR and the globin promoters in accordance with the respective globin promoter activities in erythroid cells of the BAC Tg mice and human erythroid progenitor cells. We will determine the effects of these long-range interactions on the epigenetic marks of the LCR and the globin promoters in the wt BAC Tg mice and the effects of LTR deletion on the epigenetic marks of the globin locus in ΔLTR Tg mice. In Aim 3, we will use lentiviral vectors to over-express or knockdown NF-Y and GATA-2 in human erythroid progenitor cells, in which γ-globin gene is silenced and β-globin gene is transcribed at a high level, to determine if changing the levels of NF-Y and GATA-2 can reprogram γ- and β-globin gene transcription. Project Narrative/Relevance Understanding the function and mode of assembly of the NF-Y/GATA-2/CBP/p300 complex on the ERV-9 LTR enhancer and the γ-globin promoter may pave the way for discovery of small chemical compounds that can specifically modulate this complex to preferentially activate the γ-globin gene without affecting other genes. Such γ-globin gene-specific drugs may avoid producing the undesirable side effects of currently prescribed cytotoxic drugs such as hydroxyurea.